Auditory Processing of Complex Sounds

This application is for an Administrative Supplement to Support Enhancement of Software Tools for Open Science, associated with an active parent grant “Auditory Processing of Complex Sounds”. Over the time course of this research project (now in years 25-30), we have developed a series of computational models for the responses of auditory-nerve fibers, brainstem and midbrain neurons. We have always shared our computational models in the form of MATLAB code, and these models have been used extensively by many labs in the auditory-research community. However, their use requires experience using MATLAB, access to or ownership of the MATLAB software, and significant computational resources. We have used the models in our own projects not only for physiological simulations, but also for predictions of psychophysical data based on physiological mechanisms. Based on our long-term experience developing and applying these computational tools, we are perfectly positioned to transition these efforts to better contribute to the NIH Strategic Plan for Data Science by translating our computational models to cloud-based resources for the wider community. We will also design and implement strategies to take advantage of and encourage use of the data-sharing resources on the Open Science Framework, and we will design direct connections between the Open Science Framework and our cloud-based computing tools, initially to be hosted as a web app on a public-facing virtual machine in the Data Center at the University of Rochester. Aspects of the NIH Strategic Plan for Data Science to which this proposal specifically contributes include: • Supporting storage and sharing of individual datasets, • Support of useful, generalizable and accessible tools and workflows • Broadening utility of and access to specialized tools, • Engaging a broader community, and • Enhancing stewardship.

Public health relevance
The public-health significance of the proposed supplement project is that it will contribute to the NIH Strategic Plan for Data Science, including fostering sharing of datasets, deployment and support of accessible tools and workflows, and broadening the utility of a set of computational tools to a wider community. In general, this work is intended to support the community of auditory neuroscience researchers, who are working towards a better understanding of the auditory system, and ultimately towards amelioration of hearing loss.